A Peer Recovery Coaching Intervention for Hospitalized Alcohol Use Disorder Patients

Alcohol Use Disorder (AUD) is the third leading cause of preventable deaths in U.S. and accounts for over 10%
of U.S. hospital admissions. Treatment for this population often fails to address the underlying cause of the
hospitalization: the AUD. Patients hospitalized with alcohol-related medical complications tend to have high-risk
for recurrence of alcohol-related medical problems, high rates of hospital readmissions, and poor recovery
outcomes. Methods that promote long-term recovery care are needed. Inpatient linkage to peer recovery
coaching may bridge this gap in care by providing a method of continued care for AUD recovery that offers
flexibility in recovery pathways, peer modeling opportunities, and strong social support. Pilot study results
demonstrated the feasibility of inpatient linkage to peer recovery coaching and showed evidence of decreased
alcohol consumption, increased engagement in treatment and recovery support programs, and decreased
emergency department visits. However, pilot study sample size, outcomes, and methods were limited. This
proposal seeks to overcome these limitations and build on these preliminary results by: using ecological
momentary assessments, measuring recovery using the new NIAAA definition, examining cost-effectiveness,
assessing alcohol consumption using an additional objective measure (breath alcohol content levels), and
examining social support and self-efficacy as potential mechanisms of effectiveness. This proposal will rigorously
test the effectiveness of an inpatient peer recovery coaching service called the RC-Link program on recovery
outcomes in patients hospitalized with medical complications from AUD. The program involves a bedside
introduction to a peer recovery coach during the patient’s hospitalization plus continued, recovery support for
six-months. The RC-Link program provides standardized peer recovery service that is both personalized to the
patients’ needs and generalized to provide socioemotional, instrumental, and informational social support during
every patient encounter. Aim 1 will determine the effect of the RC-Link program on frequency of heavy drinking,
biopsychosocial functioning, and remission from AUD compared to controls. Aim 2 will examine how daily
changes in perceived social support and self-efficacy influence alcohol consumption and determine whether
such associations differ between the RC-Link and control groups. Aim 3 will examine the cost-effectiveness of
the RC-Link program; hospital utilization rates will be examined as secondary outcomes. These aims will be
evaluated using a two-arm randomized controlled trial that compares the RC-Link program intervention to a
control group that receives a brief intervention and connection to a peer recovery coach after the study period.
Outcomes will be assessed at baseline, monthly during the 6-month study period, and 6-months post-
intervention. This study has potential to advance recovery care for AUD by providing a better understanding of
how long-term, inpatient-initiated peer recovery coaching influences recovery outcomes over time in this
population.

Public health relevance
PROJECT NARRATIVE Alcohol use disorder (AUD) can lead to numerous health problems and medical complications that necessitate hospitalization, yet recovery care services for the underlying addiction are rarely offered to such patients during their hospital admission. To capitalize on hospitalization as a reachable moment for initiating recovery from AUD, the proposed research will test the cost-effectiveness and efficacy of the RC-Link program, a novel hospital- initiated long-term peer recovery coaching service, on recovery outcomes among inpatients (N=750) admitted for medical complications from AUD. Results from this research will inform us as to whether this intervention represents an evidence-based, individualized model of care for AUD that can readily be implemented in the hospital setting.